Role of embryonic multipotent progenitors in hematopoietic ageing

Project Summary/Abstract
In humans, aging is associated with chronic inflammation and a decline in adaptive immunity, leading to
higher rates of infection and cardiovascular disease, two of the leading causes of death in adults over 65. These
hematologic defects are due in part to deficiencies in aged hematopoiesis, which is biased toward myeloid
lineages. Many studies on aged hematopoiesis rely on transplantation assays or isolation of specific
hematopoietic stem cell (HSC) populations for molecular analysis. While these studies highlight important
features of aged HSCs, their approaches focus on long-term (LT) HSCs, a small subset of hematopoietic cells,
often to the exclusion of other progenitor populations. Recent studies employ inducible genetic tags to track
unperturbed native hematopoiesis. Many of these studies suggest that a large number of progenitor clones,
rather than LT-HSCs, drive the bulk of adult hematopoiesis. However, the precise origin of these progenitors
remains unclear. Our preliminary work using the transposon tagging technique developed in our lab to tag cells
throughout embryonic development indicates that a large portion of adult blood bears tags associated with MPPs,
without a corresponding tag in the HSC population. Thus, these MPPs are not clonally related to HSCs, but
rather were tagged as a previously unappreciated population of embryonic MPPs (eMPPs). Mature blood
contributions from eMPPs were detected when tagging was induced as early as E9.5. However, it remains
unclear at which stage of development eMPPs first emerge, and whether earlier hematopoietic cells, such as
hemogenic endothelium, are primed to generate eMPPs. By E11.5, increased expression of several lymphoid-
associated transcripts appears to separate eMPPs from HSCs. We hypothesize that unique transcriptomic and
epigenetic features can predict eMPP divergence during development. To test this hypothesis, we will perform
single-cell ATAC-seq and RNA-seq on hematopoietic cells from embryos at several developmental stages. We
anticipate that tracking transcriptomic and epigenetic state in embryonic hematopoietic populations will allow us
to identify the emergence of eMPPs and, potentially, populations which are primed to generate them. Preliminary
data also indicate that eMPPs’ large contributions to hematopoiesis decline with age, and that eMPPs generate
the majority of mature lymphoid cells throughout all adult life. We hypothesize that eMPPs are vital to lymphoid
production, and their age-dependent decline underlies myeloid bias in aged hematopoiesis. To test this
hypothesis, we will genetically ablate eMPPs during fetal development and detect the effects of the loss of
eMPPs on the lineage balance of mature blood and expansion of HSCs in the bone marrow. Conversely, we will
attempt to rescue the aged phenotype via overexpression of Hoxb4 and Meis1, two genes associated with self-
renewal in HSCs, in MPPs. Our findings will not only elucidate the origin eMPPs in development, but also have
the potential to challenge our current understanding of aging in the hematopoietic system, providing insight into
the etiologies of many age-related hematologic defects.

Public health relevance
Project Narrative Age-related defects in the blood underlie many significant health conditions in older adults including higher risk of infections, cardiovascular disease, and myeloproliferative disorders including leukemia. Our lab has recently identified a new type of blood progenitor cell which generates the bulk of young adult blood, but falters with age, and we propose to elucidate the role of these cells in age-related blood defects. Our results may identify new mechanisms by which blood cells deteriorate with age and suggest novel screening and treatment strategies for the immune, cardiovascular, and myeloproliferative defects in older adults.